Multidisciplinary Cardiovascular Research Training

ABSTRACT: Despite what are truly modern miracles of science, diagnostics and therapeutics, cardiovascular
disease remains an immense human and societal burden. The objective of this longstanding training grant is to
prepare the next generation of MD and PhD scientists for careers in cardiovascular disease research, for
positive impact on the field. An astounding 90% of prior trainees from the last two cycles have careers which
involve research, and many prior trainees from past T32 grant cycles have become academic cardiovascular
leaders across the country. The Program consists of ten educational opportunity “Pods” spanning a range of
topic areas from translational to clinical and clinical and population science. These Pods provide trainees with
cohesive research opportunities in (1) cardiovascular aging; (2) vascular biology / thrombosis / inflammation;
(3) ion channel biology & arrhythmia; (4) cardiovascular genetics; (5) population/clinical science; (6) cardiac
myocyte biology / myopathies; (7) cardiovascular disease in women; (8) multiomics and system biology
(including metabolism); (9) heart and brain health; and (10) digital health. These latter two Pods represent new
and expanded training opportunities to leverage major new institutional programs, and several of the original
Pods have been expanded/reorganized. The grant, now in its 24th year, provides both didactic training as well
as research immersion for MD, MD PhD, or PhD trainees. It has trained a large number of investigators, many
of whom have led paradigm-changing and sustained research programs and have trainees of their own. Many
of the recent trainees have obtained NIH K- or even R-level funding, with 67% remaining in academia and 23%
having secured industry positions. The T32 core leadership team consists of three senior faculty, each of
whom has a substantial portfolio of research and training, who are drawn from the fields of vascular biology,
cardiovascular pharmacology, and cardiometabolic disease. The program is integrated with common didactic
coursework including a grant-writing workshop, instruction in the responsible conduct of research, and a
diverse array of topical scientific seminars. The glue which holds this program together as a cohesive whole is
the purposeful interactions of trainees at Division-sponsored trainee luncheons, and an interactive networking
program that facilitates interchange among trainee peers and preceptors. Trainees are guided in their
individual didactic programs and experiential learning in labs (bench or computational) with a regular cadence
of meetings with T32 Program Executive leadership, as well as a Trainee Advisory Committee. Metrics for
success include coursework completion, public data presentations, publications, and preparation of an
individual (mock or real) training grant subjected to internal review and feedback. An innovation for this
program includes interaction of trainees with a group of less senior but highly accomplished near-peer
mentors, to supplement the in-depth and frequent Preceptor interactions. The overall goal here is to create and
sustain the next generation of cardiovascular scientists to focus on the most important disease of our era.

Public health relevance
PROJECT NARRATIVE This past decade has been marked by a cessation in the previous steady decline of cardiovascular deaths, and potentially even a slight uptick, creating a public health imperative to better understand the causes and treatments for cardiovascular disease. Building on an exceptionally strong prior track record of academic training, this proposal seeks to train the next generation of investigators with modern techniques for cardiovascular research, including in new areas particularly relevant to the aging demographics of the American population, leveraging new insights into mechanisms of cardiovascular disease for all and especially for women, and the digital health revolution. Working with a diverse and experienced cohort of faculty preceptors, trainees will immerse themselves in both experiential/project-based learning as well as didactic training in critical elements of cardiovascular science, to emerge as future thought leaders to better understand, diagnose, and treat a broad spectrum of cardiovascular diseases.